Determining the impact of early adversity on the developing vertebrate brain

PROJECT SUMMARY
In humans, chronic stress in children and adolescents has long lasting and debilitating effects that persist well
into adulthood. Victims of childhood trauma have increased susceptibility to develop anxiety disorders such as
post-traumatic stress (PTSD), increased propensity to substance abuse, hyper-aggression, and, in some cases,
psychiatric disorders such as schizophrenia. Despite the prevalence of childhood trauma, little is known about
how early life adversity impacts the development and function of the brain. This proposal utilizes a novel model
of early life adversity (ELA) in the developmental and molecular neurogenetic system, the zebrafish. We will
examine the impacts of ELA on hormonal, neuronal and genetic factors underlying brain development, and study
how they are altered by ELA. The study utilizes powerful tools and approaches established in zebrafish, including
whole-brain imaging of neuroanatomy and neuronal activity, transgenic reporters of glucocorticoid singling, and
genetic screening using CRISPR/Cas9 technology at multiple developmental time points. Because of the high
homology of genes and neuronal circuits underlying stress between fish and humans, we expect the findings
from this study to reveal critical insight into what biological effects childhood trauma has on the developing brain.

Public health relevance
PROJECT NARRATIVE Childhood trauma has robust and long-lasting effects on behavior and physiology that persist into adulthood, yet how early life adversity alters the development and function of the brain remains poorly understood. This proposal uses a novel model of early life adversity (ELA) in zebrafish to examine the consequences of ELA on the development of the brain at genetic and neuronal levels. These studies will enhance our understanding of how childhood trauma impacts the development of the brain and will provide a groundwork for further investigation of altered genetic pathways and neuronal aberrations resulting from childhood trauma.